Designed nanopores for single-molecule protein sequencing

Maglia
PROJECT SUMMARY
Nanopores have emerged in the past few years as promising single-molecule sensors. The basic
concept of nanopore sensing is to apply a potential across individual nanoscale pores embedded in
insulating material and observe the disruption of the ionic flow caused by single molecules entering
the pore. Ionic currents through protein pores have been utilized to recognize tiny differences in
molecules in solution. Most notably, arrays of thousands of nanopores integrated in low-cost and
portable devices are now capable of sequencing DNA at the single-molecule level. The main
challenge of nanopore sensing is the inability to control the transport of molecules across the
nanopore and to fabricate protein pores with a bespoke diameter and geometry that can recognize
individual amino acids.
The aim of this proposal is to design a new generation of protein nanopores with advanced
functionalities that will take on the next grand challenge of sequencing single proteins.
In order to sequence proteins, the designed nanopores must unfold a target protein, control the
speed of its transit across the nanopore and recognize individual amino acids. Our approach is to
bioengineer complex nanopore-device that will unfold target proteins and feed the linearized
polypeptide through the nanopore where single amino acids will be recognized by modulations of
the nanopore current. Alternatively, we will engineer the nanopore machine to cleave the polypeptide
at specific positions and the fragmented peptides will be read sequentially as they translocate across
the nanopore
The specific objectives are:
Control of transit: Supramolecular nanopore devices will be designed and engineered to integrate
one or more molecular machines that will unfold proteins and control their linearized transport across
a nanopore
Recognition: We will design new and engineer existing nanopores that will allow the stretching of
polypeptides as they are passing the nanopore and the recognition of amino acids and peptides.
Our nanopore devices will be used to develop the first technology to sequence full-length single
proteins. Compared to the state of the art ‘shotgun proteomics’, the nanopore approach will allow
long polypeptide reads, recognition of low-abundance proteins, including biomarkers linked to
diseases, and real-time monitoring with minimal cost, time and sample preparation.
1

Public health relevance
Maglia PROJECT NARRATIVE Among the techniques that have been proposed to sequence proteins at the single-molecule level, nanopores promise the high throughput sequencing of unlabelled and full-length proteins. The main challenges lie in controlling the unfolding and transport of proteins across nanopores, stretching the polypeptides and recognizing individual amino acids. Using his unique skills, the applicant will design nanopore-machines that will tackle the fundamental challenges in single-molecule nanopore sequencing. 1